Early Career Development of Clinician-scientists in Otolaryngology and the Communication Sciences

PROJECT SUMMARY
The importance of physician-scientists in maintaining a close connection between basic research and the issues
encountered in clinical practice has been widely recognized. Nevertheless, the number of physician-scientists
continues to decrease, particularly in surgical subspecialties. A combination of effective mentorship and a strong
foundation in research methodology and data analysis is crucial for building a successful career as a clinician-
scientist. Unfortunately, for trainees and early career faculty in otolaryngology and the communication sciences
the availability of such support varies widely between programs, often due to inherent disparities in departmental
or institutional resources. We are seeking supplemental support for the Research Symposium for Clinician-
Scientist Development in Otolaryngology and the Communication Sciences. This yearly national
conference will assemble promising otolaryngology residents, fellows, and early career faculty for a host of
lectures, workshops, and panels that focus on keys to research success. Support is requested for 1) organization
of a ‘Research Boot Camp’ that provides instruction in research methodology, study design, grantsmanship,
manuscript review, and other aspects of a successful research enterprise, 2) resources for competitively
awarded travel grants to promising early career otolaryngologists, and 3) support for successful otolaryngology
surgeon-scientists to lead workshops and panels on career development and maintaining as successful research
program. This intensive experience will both motivate participants and provide them with the tools needed to
achieve success in translational research. This comparatively small financial investment will pay future dividends
by maintaining and diversifying the biomedical workforce in Otolaryngology-Head and Neck Surgery and the
Communication Sciences.

Public health relevance
RELEVANCE The continuing decrease in the number of surgeon-scientists may significantly limit opportunities for future scientific discovery and innovation, and mounting evidence suggests that this decline is due to a ‘pipeline’ problem. Trainees in Otolaryngology-Head and Neck Surgery and the Communication Sciences can face geographic, financial, and systemic barriers that may discourage pursuit of a career as a surgeon-scientist, thus new and innovative approaches are needed to encourage careers in research and to provide research training and effective mentorship. The Research Symposium for Clinician-Scientist Development in Otolaryngology and the Communication Sciences will address this problem by organizing a ‘Research Boot Camp’ that provides instruction, mentorship, and career development tools for attendees.